A digital pill system to measure and support acamprosate adherence in individuals with alcohol associated liver disease

Abstract
Alcohol use disorder (AUD) is a devastating disease with significant morbidity and mortality, particularly due to
alcohol-associated liver disease (ALD). Early intervention and optimal medication adherence to medications for
AUD (MAUD) can decrease alcohol use and prevent the progression of liver damage. Yet, adherence to
MAUD, especially acamprosate - the preferred medication for AUD in individuals with ALD - remains
suboptimal. This K23 proposal seeks to leverage an innovative digital pill system (DPS) that directly measures
acamprosate ingestion and pairs it with a cognitive behavioral therapy (CBT)-based intervention. The DPS will
collect real-time adherence data to contextualize and personalize smartphone-delivered adherence support,
potentially revolutionizing how adherence is managed in high-risk AUD populations. To achieve this goal, we
will 1) develop a user-centered adherence intervention paired with a DPS (AcamproSync) to informed tailored
support for participants with ALD and AUD taking acamprosate; 2) test the feasibility and acceptability of
AcamproSync through a pilot randomized controlled trial in N=50 individuals with AUD and ALD prescribed
acamprosate compared to treatment as usual; and 3) assess user experience and barriers to the
implementation of AcamproSync, guided by the Reach-Effectiveness-Adoption, Implementation, and
Maintenance (RE-AIM) framework. By addressing key gaps in adherence to MAUD, this project has the
potential to significantly impact AUD treatment outcomes. This study will also provide foundational data for the
development of a scalable digital health-based intervention to improve adherence that has trans-NIH
applicability to other high priority health issues.

Public health relevance
Narrative Alcohol use disorder (AUD) is a significant public health problem, particularly in individuals with alcoholassociated liver disease (ALD). Medications, such as acamprosate, have been shown to decrease alcohol craving, alcohol use, and prevent progression of liver disease; however, adherence is suboptimal. This project seeks to develop and test a novel digital pill system (DPS) that measures real-time medication ingestion and pairs it with a cognitive behavioral therapy (CBT)-based intervention to provide personalized, data-driven adherence support. By using direct, real-time medication use data and providing personalized support through a smartphone intervention, this research has the potential to offer a new and improved way to improve medication adherence for people with AUD and ALD.